A novel and efficacious electrotaxis system for enhancing chronic wound healing

PROJECT SUMMARY. Chronic wounds (CWs) are currently affecting 1 – 2% of the population in the U.S. They
have a devastating impact on patients’ health, functional status, and overall quality-of-life. CWs are characterized
by delayed skin tissue regeneration processes due to the impaired cell migration of dermal fibroblasts, vascular
endothelial cells, and keratinocytes in CWs. Current clinical standard-of-care does not specifically correct these
physiological impairment. More advanced treatments, such as growth factors, microRNA-targeting therapies,
and stem cells have shown a better efficacy in enhancing cell migration and skin tissue regeneration. However,
they face challenges of low efficacy in human patients, inefficient delivery and low stability of therapeutics, and
high cost. Due to the limitations of the current CW therapies, there is a critical need for novel treatment
technologies that can be easily applied to CWs and efficaciously enhance cell migration and skin tissue
regeneration without imposing a high financial burden on patients. Direct current (DC) electric field (EF) is
capable of guiding directional migration and increasing the migration speed of keratinocytes, dermal fibroblasts,
and vascular endothelial cells in vitro, a phenomenon called electrotaxis. Electrotaxis has also led to accelerated
wound closure in in vitro scratch wound healing assays. Compared to the current technologies, electrotaxis
provides unique advantages including highly directional cue for guiding cell migration, rapid cellular responses,
easy treatment application, programmable treatment parameters, and low cost. Despite the successful
application of electrotaxis in in vitro, the in vivo wound healing efficacy of electrotaxis is limited and insignificant.
The reason for this low efficacy is that the DC EF strength that is effective in in vitro cannot be safely applied to
in vivo wounds using the conventional electrical stimulation (EStim) electrodes without inducing tissue damage.
Our long-term goal is to develop safe and efficacious EStim-based technologies for the CW treatment. Toward
this goal, our lab recently developed a hydrogel ionic circuit (HIC) electrode that can safely apply high-strength
DC EF to biological tissues by minimizing electrochemical reaction-induced interfacial pH and temperature
changes. Our main objective in this proposal is to develop a novel wearable HIC-based electrotaxis system with
a high flexibility and a reduced size to facilitate the healing of CWs. Our central hypothesis is that our wearable
HIC-based electrotaxis system can safely apply high-strength DC EFs to promote directional migration of
keratinocytes, dermal fibroblasts, and vascular endothelial cells into CW at increased speed, which will lead to
accelerated CW healing. Our Specific Aims are: 1) to develop a wearable HIC-based electrotaxis system that
can safely apply high-strength DC EF to induce electrotaxis cell migration; 2) to determine the in vivo safety and
efficacy of our wearable HIC electrotaxis system in enhancing CW healing. If successful, our high-impact
technology has the potential to enhance the clinical treatment efficacy of CWs, reduce the amputation and
mortality rate, reduce the financial burden on patients, and improve the overall quality-of-life of CW patients.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it will develop a novel, highly efficacious electrotaxis system to accelerate the skin tissue regeneration and the healing of chronic wounds. This project is relevant to NIBIB’s mission by developing transformative bioelectric technology with potential to enhance the therapeutic effect for chronic wounds.